Development of AS01b Mimics by Replacing QS-21 with a New Saponin Adjuvant

AS01b (composed of the molecules QS-21 and MPL) is a powerful adjuvant best known for being a component of the FDA-approved Shingrix vaccine. Despite its successful track-record as an effective adjuvant, accessibility to AS01b as an adjuvant for use in novel vaccines is a concern due to the limited nature of the saponin molecule QS-21. The awardee seeks to address this problem by developing a mimic of AS01b by replacing QS-21 with a novel saponin molecule.